DOT Selfie: A Mobile Health Intervention with Transfer of Social Bundle Incentives to Increase Treatment Adherence in Tuberculosis Patients in Uganda

1.0 Abstract Tuberculosis (TB) is one of the deadliest infectious diseases and a killer of 1.7 million people worldwide in 2016, majority of whom were in low- and middle-income countries. Medication non-adherence is a common, complex, and costly problem. Non-adherence to treatment is a major obstacle to TB control: it reduces cure rates, prolongs infectiousness, and contributes to the emergence of multi-drug resistant strains of TB. Careful monitoring and support of treatment adherence is needed to mitigate the rapid emergence of MDR-TB and other adverse disease outcomes. The lack of a sufficient number of health workers and the cost of travel makes it particularly challenging to implement the current standard in-person directly observed therapy (DOT). We propose to adapt and test an existing mobile health intervention -video directly observed therapy (VDOT), for use in the local Ugandan context. The adapted intervention dubbed “DOT Selfie” is expected to provide a new alternative way for health providers to monitor patients remotely. First, “DOT Selfie” will entail a patient using a smartphone to record and send a time-stamped encrypted video showing his/her medications intake each day. This video component will directly substitute the need for daily face-to-face meetings between the provider and patient thereby minimize costly travel. Second, the patient will also receive daily SMS text reminders translated in Luganda and a weekly reward if they send their videos. This component will enhance patient- provider interaction while motivating desired adherence behavior. The provider logs on a secured computer system to verify treatment adherence. We hypothesize that, by eliminating the need for daily travel, allowing patients to take their pills anywhere and providing incentives to TB patients, DOT Selfie will increase treatment adherence. The long-term goal of this project is to establish DOT Selfie as an effective way to improve medication adherence in TB treatment in an African context. To achieve this goal, it will be critical to perform reliable research to assess effectiveness of contextualized mHealth tools and also to build a knowledgeable and competent workforce that will properly implement mHealth interventions in Africa. In partnership with Makerere University in Uganda, the Uganda National TB Program and researchers at the University of Georgia, the team will work to address the scientific and capacity building objectives through these Specific Aims. First, we will conduct qualitative interviews to identify perceived barriers to use of mHealth tools among patients and providers. Second, we will test the adapted DOT Selfie intervention for monitoring adherence among 30 TB patients compared to those in standard of care. Finally, we will use a multi-prong approach to build and strengthen the capacity for mHealth research at Makerere University and within the National TB Program in Uganda. The results will be applicable to other African settings and to a range of chronic diseases with lifelong treatment such HIV/AIDs.

Public health relevance
Project Narrative This project will pilot DOT Selfie, an adapted mobile-based intervention that uses video to observe pill intake by patients to improve adherence monitoring of TB treatment in Uganda. The intervention is based on Video Directly Observed Therapy (VDOT), which consists of a smartphone App for recording and sending videos to a secure server. The sent videos are immediately accessed and viewed by health workers eliminating the need to travel to the patients' home or work place. The proposed project will innovatively add a low-cost weekly incentive in form of prepaid access to social media or voice calls to chat with their friends and family. We expect the intervention to improve adherence to TB treatment and provide a feasible alternative for the Uganda National TB Control Program that helps to overcome practical challenges of health worker shortages and costly travel.